Pro-apoptotic Drugs as Host-Directed Treatments for Pulmonary Tuberculosis

During the early phase of infection, Mycobacterium tuberculosis proliferates in macrophages and other
cells, preventing apoptosis by the induction of proteins such as from the Bcl-2 family, leading to necrosis of the
infected cells. Necrosis increases tuberculosis (TB)-associated morbidity by causing tissue destruction,
inducing inflammation, promoting fibrosis, and impairing vascular supply, thereby reducing the penetration of
antimicrobials and immune cells to the areas where they are needed most. We have recently demonstrated
that adjunctive use of navitoclax, an orally bioavailable, pro-apoptotic small molecule Bcl-2 inhibitor (in clinical
trials for cancer treatments, with excellent safety profile), improves bacterial elimination and decreases lung
damage in animal models of TB. Additionally, navitoclax has anti-fibrotic effects, which can reverse and
prevent lung fibrosis and may promote antibiotic penetration into TB lesions. In fact, post-TB lung disease is a
recognized consequence of pulmonary TB, with associated chronic adverse outcomes beyond the TB
treatments, including bronchiectasis, poor lung function and respiratory symptoms. Our central hypothesis is
that navitoclax (or similar pro-apoptotic drugs) could be used as a cell death mechanism (CDM)-based small
molecule, host-directed therapy (HDT) approach to shorten TB treatments, and prevent post-TB lung disease.
To understand how these novel therapeutics impact the lung immune landscape, remodeling and bacterial
clearance, we have developed several novel, clinically translatable positron emission tomography (PET)-based
imaging biomarkers to longitudinally profile lesional characteristics in live animals: 18F-ICMT-11 for apoptosis,
18F-FAPI-74 for fibrosis, 11C-rifampin and 18F-pretomanid (both chemically identical to the parent antibiotic) for
tissue antibiotic exposures as well as advanced magnetic resonance and computed tomography imaging to
visualize pulmonary damage and necrosis. Finally, we have developed complementary high-dimensional
immunophenotyping by flow cytometry to assess the lung immune landscape, remodeling and fibrosis. We will
develop CDM-based small molecule HDT approaches for TB treatments, which brings together cutting-edge
technologies and cross-disciplinary expertise in TB pathogenesis (Jain), pulmonary immunology (D'Alessio)
and oncology (Carroll). There are currently no HDTs approved for clinical use for the treatment of pulmonary
TB. Therefore, in this proposal, we will leverage our expertise in animal models of TB, advanced whole-body in
vivo imaging and high-dimensional immunophenotyping to gain mechanistic insights on the role of pro-
apoptotic drugs to shorten treatments for drug-susceptible and multi-drug resistant (MDR) pulmonary TB as
well as to prevent post-TB lung disease. Our goals are to utilize novel pro-apoptotic HDTs to develop short (2-3
months versus current 4-6 months or longer), and efficacious TB treatment regimens which also prevent /
improve post-TB lung disease, as well as develop novel clinically-translatable imaging approaches to expedite
the development of pro-apoptotic drugs for shortening TB treatments.

Public health relevance
Our overall goals are to utilize novel pro-apoptotic host-directed therapies to develop short (2-3 months versus current 4-6 months), and efficacious TB treatment regimens which also prevent / improve post- tuberculosis lung damage, as well as develop novel clinically-translatable imaging approaches to expedite the clinical development of pro-apoptotic drugs for shortening TB treatments.